Research Education Component

PROJECT SUMMARY/ABSTRACT – RESEARCH EDUCATION COMPONENT (REC)
A priority of the 2020 National Institute on Aging report, Strategic Directions for Research 2020-2025, is to
“attract and train more researchers from diverse scientific and cultural backgrounds”. Since 1997, the Center
for Aging in Diverse Communities (CADC) at the University of California San Francisco (UCSF) has been
refining its highly successful mentoring program to increase the number of very skilled, early-stage diverse
investigators with successful and sustained careers in health disparities research with older populations (aging-
related health disparities research). The primary role of CADC’s REC is to provide comprehensive mentoring,
education and training, and career development to diverse scientists focused on the CADC research theme of
understanding the multilevel social and behavioral mechanisms of health disparities that impact older adults
and developing community and practice-based interventions to achieve health equity. We do this under the
scientific leadership and coordination of the Leadership Administrative Core (LAC), and in collaboration with
the Analysis Core (AnC). During the 2018-2023 cycle, CADC’s REC has mentored 20 CADC Scientists (19
pilot and one Diversity Supplement recipient). Since becoming CADC Scientists, those 20 investigators have
made significant contributions to aging-related health disparities research by publishing 196 articles (87 or 44%
as first or last author) and securing 52 new grants as PI or MPI. In this proposed renewal the 9 CADC Mentor
Faculty (including 4 alumni CADC Scientists) collectively have decades of aging-related health disparities
research experience and a robust track record of mentoring diverse early-stage investigators in establishing
sustained research careers. The CADC REC proposes the following specific aims: 1) select 3-4 CADC
Scientists per year from diverse backgrounds who have proposed innovative pilot research projects focused on
the research theme of the Center; 2) deliver our comprehensive mentoring program to CADC Scientists to help
them develop independent, sustained careers in aging-related health disparities research; and 3) deliver a
robust education program to our CADC Scientists focused on research topics and methods relevant to aging-
related health disparities research. To achieve these aims, two alumni CADC Scientists (from 2018-2023
cycle) joining our faculty will enhance our program by further diversifying CADC’s faculty and leadership, and
through near-peer mentorship to our Scientists. We will expand the REC’s reach via an affiliation with Hispanic
serving University of California Merced (UCM), deepen collaborations with synergistic NIH supported aging-
related centers and programs at UCSF, and create additional mentorship, educational, and networking
opportunities for CADC Scientists during our new annual retreat, and through our innovative Mentor Resource
Group, comprising highly experienced aging-researchers from across UCSF. Through comprehensive
mentorship, robust education and innovation, CADC’s REC will build on its already strong record of promoting
research workforce diversity, with the goal of meeting the needs of aging populations to achieve health equity.